Modulating the localization and persistence of microbial neoantigen vaccine vectors to enhance therapeutic efficacy

PROJECT SUMMARY
The development of neoantigen cancer vaccines is transforming cancer immunotherapy – providing an approach
to stimulate pre-existing and de novo anti-tumor T cell responses. These vaccines are designed to introduce
tumor-specific neoantigens to activate the immune system, and can be amplified through tumor lysis–mediated
epitope spreading. The focus of this project is to improve the therapeutic efficacy and safety of microbial
neoantigen vaccines by modulating both their localization and persistence within the tumor microenvironment.
Microbial vectors, such as E. coli Nissle 1917, have the natural ability to target hypoxic, immunosuppressed
regions within tumors and deliver encoded neoantigens to elicit strong T cell responses. However, for these
vaccines to be most effective, it is critical to control where and for how long bacteria persist in the body, as this
impacts both their therapeutic effectiveness and safety profile.
This proposal has three key objectives. First, it aims to explore how bacterial localization within tumors affects
immune responses and overall therapeutic outcome. By understanding where bacterial vectors deliver encoded
cargo – whether in tumor or non-tumor tissues – and the impact this has on immune activation, this project will
provide insights that can improve cancer vaccine design. Second, these studies will investigate how bacterial
persistence influences the strength and specificity of neoantigen-driven T cell responses. By regulating the
duration of bacterial survival within the tumor microenvironment, this project seeks to balance the delivery of
neoantigens with safety concerns. Third, this project will explore the use of inhalation-based delivery of microbial
vaccines in a lung metastasis model. This alternative to intravenous delivery could offer a more targeted and
safer approach, particularly for lung metastases, where treatment options are currently limited.
This research addresses significant gaps in current cancer therapies, particularly for hard-to-treat cancers
such as metastatic melanoma and lung metastases. Existing treatments are often insufficient, and many patients
experience relapses or develop resistance to immunotherapies. By fine-tuning the location, persistence, and
delivery method of microbial neoantigen vaccines, this project aims to create a safer, more effective cancer
vaccination approach that could reduce off-target effects and improve patient outcomes. If successful, this work
could lead to significant advancements, moving these treatments closer to clinical application.

Public health relevance
PROJECT NARRATIVE This project focuses on developing microbial neoantigen vaccine vectors that can target and enhance immune responses within the tumor microenvironment. Our approach leverages the natural ability of bacteria to home to tumors and modulates the localization and persistence of these bacterial vectors to improve their therapeutic efficacy while minimizing toxicity. If successful, this research could lead to safer, more effective neoantigen delivery vectors for difficult-to-treat cancers, such as metastatic melanoma, ultimately improving patient survival and reducing side effects associated with conventional treatments.